Neuronal Mechanisms Underlying Sex Differences in Dystonia

Dystonia is characterized by involuntary muscle contractions that cause twisting movements and postures. Many
dystonias are more common in females than in males yet the mechanisms underlying these sex differences are
largely unexplored. Basal ganglia dysfunction is consistently implicated across many forms of dystonia. The
major input structure of the basal ganglia is the striatum where estrogen exerts neuromodulatory effects. In fact,
the physiological properties of striatal spiny projection neurons (SPNs) are known to vary depending on biological
sex and estrous cycle phase. Direct pathway SPNs (dSPNs) project to the internal globus pallidus to promote
movement. Indirect pathway SPNs (iSPNs) project to the external globus pallidus to inhibit movement. Although
dSPNs and iSPNs are segregated into separate pathways, they act in concert to mediate and refine movements.
In dystonia patients, this coordinated activity is disrupted as functional imaging studies and microelectrode
recordings suggest that both dSPNs and iSPNs are dysfunctional. However, the mechanisms underlying both
SPN pathophysiology and sex differences in dystonia remain unknown.
Several challenges have stymied our ability to understand the pathophysiology and the relationship to biological
sex in dystonia. First, information obtained by studying patients is, by necessity, quite limited. Second, despite
the epidemiological studies demonstrating sex differences in the expression of dystonia, sex as a biological
variable is rarely incorporated into studies examining mechanisms underlying dystonia in patients or animal
models. Third, we lack foundational studies in healthy controls that disentangle the effects of biological sex on
striatal cell types. Indeed, studies characterizing sex differences in normal striatal physiology have not
distinguished between SPN subtypes, while studies examining the molecular properties of dSPNs and iSPNs
have not examined sex as a biological variable. This proposal addresses these gaps in knowledge.
Our understanding of the pathophysiology of dystonia has also been hampered by the lack of animal models
with sexually dimorphic dystonia caused by striatal dysfunction. To address this gap, we created a knockin
mouse model of DOPA-responsive dystonia (DRD). In patients, DRD is female predominant, like many forms of
dystonia in humans. DRD is also a prototype disorder for understanding basal ganglia dysfunction in dystonia In
DRD mice, the striatum plays a central role in mediating dystonia and dSPN and iSPN signaling is disrupted.
Further, the presentation of dystonia in DRD mice is significantly different between males and females and the
dystonia fluctuates with the estrus cycle. Thus, for the first time, it is possible to elucidate the neural code of
dystonia in the context of the mechanisms that drive the sex differences. The Specific Aims are: 1. to determine
the role of ovarian hormones in the expression of dystonia. 2. to identify the molecular signature of dystonia in
dSPNs and iSPNs in male and female DRD mice. 3. to define the pattern of dSPN and iSPN activity underlying
dystonia in male and female DRD mice.

Public health relevance
The proposed experiments will not only define the molecular and physiological signatures of dystonia but will do so in context of biological sex, a known risk factor for the disorder but one that is largely unexplored. Understanding and recognizing sex differences in the pathomechanisms of dystonia will provide a foundation that is critical for optimizing diagnoses, targeting treatments, and designing clinical trials.